CSHL Course on Advanced Sequencing Technologies & Bioinformatics Analysis

This Cold Spring Harbor annual short course will train a broad cohort of biological and biomedical scientists in the latest sequencing technologies and the downstream bioinformatics analysis of the large quantities of sequence data generated by these technologies. The proposed Cold Spring Harbor Laboratory course on Advanced Sequencing Technologies & Bioinformatics Analysis is to be held November 2021-2025. A broad range of scientific questions are amenable to exploration through modern approaches in DNA/RNA sequence analysis, and we therefore anticipate applications from individuals working in areas across the biological and biomedical sciences, from evolution and development to plant and animal physiology to cancer and host response to infectious diseases. Students will be instructed in the detailed operation of several revolutionary sequencing platforms, including library construction procedures, general data processing, and in-depth data analysis. Common experimental approaches enabled by massively parallel sequencing technologies will be explored in detail, including de novo DNA sequencing and assembly of genomes, DNA re-sequencing of known cancer genes, bulk transcriptome profiling, single-cell transcriptome profiling, small variant discovery/interpretation and other approaches that are tailored to the student's research areas of interest. Expanding the bioinformatics component of the course, students will be introduced to Unix command-line, important file formats, alignment, data visualization, basic scripting in R, bash and other program languages, cluster job submission and bioinformatics pipeline development. Guest lecturers contribute to the course and are encouraged to highlight their own applications of these revolutionary technologies. This specialized training in a residential setting immediately impacts the progress of the trainees’ research, and promotes collaboration and exchange of ideas between faculty and trainees, and thus represents a significant and valuable investment towards accelerating genome research. The advanced scope of the course will be twinned with an innovative educational design, including the broader dissemination of the course lectures and associated material and problem sets via tailored online learning tools. Significant outreach to and engagement of all research communities and individuals will be combined with dedicated mentoring and follow-up to help retain and provide ongoing academic support of individuals with specific research interests that intersect with the scope of the course.

Public health relevance
This advanced course offers the latest training in DNA and RNA sequencing and analysis. The explosion in genomics over the past several decades has spawned a range of sequencing technologies and approaches that each have advantages and disadvantages over competing approaches, even as the underlying cost drops precipitously. Biomedical scientists now use DNA sequencing technologies not just to catalog the genomes of thousands of species, but to probe genetic variation within species, including multicellular organisms such as plants and animals, fungi, bacteria and viruses. Techniques such as single cell sequencing allow for sampling of normal tissue across time and space, providing an ever more in-depth understanding of normal development and disease progression, while RNA sequencing in its many iterations provides detailed molecular analysis of the genome expression and regulation, informing both our understanding of normal biological processes and the progression of diseases such as cancer and viral infections. The plethora of sequencing technologies together produce an avalanche data, and practitioners must also be trained in the latest bioinformatics tools and approaches to make sense of and interpret the unprecedented volumes of information generated experimentally. The course will enroll a diverse cadre of students ranging from graduate students to group leaders, promoting collaboration and exchange of ideas between faculty and trainees, and thus represents a significant and valuable investment towards accelerating genome research and its application to biomedical and biological questions. Effort will be made to broaden access to this educational resource using a combination of hands-on in-person and online training.